Blood Alcohol Content Limit Laws and Alcohol-Related Outcomes

PROJECT SUMMARY
Numerous studies show that Blood Alcohol Content (BAC) limits for driving are effective at reducing
alcohol-related car crashes in the general population and among young adults. However, few studies
have examined how BAC limit laws are related to alcohol consumption and alcohol-related outcomes
beyond drunk-driving. Examining how BAC laws are associated with alcohol-related outcomes is
crucial because stricter BAC limit laws have unintended benefits beyond reducing drunk driving. As of
June 2024, Utah is the only US state with a BAC limit of 0.05 (Utah passed legislation in 2017 with
enforcement beginning in 2019). Forty-nine states remain with a 0.08 limit, though Delaware, Hawaii,
and Washington had similar legislation proposed but not passed in 2018. In response to a rise in traffic
fatalities, Washington and Hawaii are again considering lowering the BAC limit for driving to 0.05 in
2024, as is Connecticut. Given that this legislation did not pass in Washington or Hawaii before, data
regarding how lower BAC limits are related to outcomes besides drunk driving could help influence
policy-making efforts. The proposed secondary analysis project, “Blood Alcohol Content Limit
Laws and Alcohol-Related Outcomes,” will provide this information by utilizing causal methods
and existing datasets: 1) 1970-2024 alcohol policy data that includes BAC limits laws and other general
population policies regarding alcohol availability and tax data that can be used to adjust for potential
confounding; and 2) alcohol-related outcome data from the National Alcohol Survey, Behavioral Risk
Factor Surveillance System, per capita sales, and Vital Statistics mortality files (excluding deaths due
to traffic fatalities). Specifically, Aim 1. is to examine how BAC limits for driving are related to alcohol
consumption and alcohol-related mortality outcomes in the general population. Aim 2. involves
examining how BAC limits for driving are related to alcohol consumption and alcohol-related mortality
outcomes among young adults. Finally, Aim 3. is to examine how alcohol consumption and alcohol-
related mortality have changed in Utah since its implementation of the 0.05 BAC limit in 2019. These
aims are particularly timely given 2024 legislation proposing to lower the legal BAC limit for driving to
0.05 in Washington, Hawaii, and Connecticut.

Public health relevance
PROJECT NARRATIVE Whether BAC limit laws are related to alcohol consumption and alcohol-related outcomes beyond drunk-driving remains unknown. Examining how BAC laws are associated with alcohol-related outcomes is crucial because stricter BAC limit laws might have unintended benefits beyond reducing drunk driving. This research will inform ongoing efforts to reduce the BAC limit to 0.05 across the United States.